Mapping and targeting 3D regulatory elements in leukemia and lymphoma-Supplement

Project Summary/Abstract (underlined are the added text and data related to this administrative supplement)
Despite cancer being typically depicted as a genetic disease, aberrations in epigenetic regulation and gene
expression play a determinant role in transformation and response to therapies. Increased chromatin plasticity
gives a survival advantage by expanding epi-clones' repertoire and allowing them to react to the immune system,
environmental stress, or exogenous treatments. Investigating which genetic and epigenetic aberrations alter
chromatin homeostasis and how they shape tumor heterogeneity is thus a critical challenge to designing
effective targeted approaches and predicting disease risk. Our team previously investigated changes in large
3D structures using T-cell acute lymphoblastic leukemia (T-ALL) as a model of study. More recently, using
H3K27ac HiChIP analysis of enhancer-promoter interactions in T-ALL, we mapped and characterized the
biological role of 3D “hubs” as DNA elements that interact with multiple other loci. What we proposed in our
recent award application is to expand our analysis and provide a complete characterization of 3D hub
interactions in T cell leukemia (T-ALL), the immature early T cell progenitor leukemia (ETP-ALL), and T cell
lymphoma, creating a continuum that spans normal T cells, their progenitors and malignant counterparts. By
leveraging the mapping of 3D hubs at multiple levels, we expect to better define which are rewired by
transformation and contribute to tumor progression or response to drug treatment.
In this supplement, we test the hypothesis that cancer health disparities (CHD) are caused -at least in part- by
epigenetic changes, and specifically distinct 3D chromosomal organization leading to different expression of
genes that control cancer (leukemia) cell self-renewal (stemness), growth and response to drug treatments. We
will focus on differences between patients of white (European) and African-American (AA) ancestry, as it is well
established that AA patients are at higher risk of certain types of blood cancers, including acute myeloid
leukemia (AML). Not only are outcomes worse for Black patients, but also these same patients enroll in clinical
trials in lower frequencies and do not have adequately stored blood samples. Our team has recently studied
the exomes and transcriptomes of 100 African-American AML patients and found that: a) distinct mutational
profiles/frequencies, b) different intrinsic and/or extrinsic dysplasia-causing stressors (like inflammation), c)
Black patients with defined mutational profiles had inferior disease free (NPM1, NRAS) and overall (IDH1/2)
survival, and, d) transcriptional profiles differed between Black and White patients with NPM1 mutations. What
was more important was that the incorporation of ancestry-specific risk markers into current genetic risk
stratifications changed risk group assignment for one-third of Black patients and improved their outcome
prediction. We thus propose to test the innovative idea that cancer health disparities are not only due to
genetic or socio-economic causes, but they are also influenced by epigenetic changes.

Public health relevance
Project Narrative This application is based on the hypothesis that 3D chromosomal interaction hubs represent regulatory units responsible for the transcription of key genes and serve as 'headquarters' of cellular identity. We show that such 3D hubs coordinate the tumorigenic program and shape therapy responses in human leukemia and lymphoma. In this administrative supplement, we expand these studies and test the hypothesis that 3D nuclear/chromosomal changes and epigenetic regulation can explain treatment response disparities in African-American patients with acute leukemia.